Developing and Assessing Wearable MEG for Children

Project Summary/Abstract
Childhood epilepsy accounts for 470,000 cases in the US and 10.5 million cases worldwide. Approximately
30% of children with epilepsy have seizures that are pharmacologically intractable, making these patients
candidates for surgical intervention. In adults with intractable epilepsy, pre-surgical workup involves source
localization of interictal epileptiform discharges (IEDs) from magnetoencephalography (MEG). Source locali-
zation of IEDs on MEG are increasingly utilized as a routine component of the presurgical evaluation to local-
ize epileptic tissue. However, although many surgical epilepsy programs have an MEG center, this technology
is not routinely available for use in children because current SQUID-based MEG systems use fixed adult-
sized sensor helmets not appropriate for pediatric head sizes that vary with age. A new MEG technology
based on optically pumped magnetometers (OPM) is emerging that can overcome this challenge because it
can accommodate variable head sizes. However, to translate this sensor technology to pediatric populations,
a system that is age-appropriate and robust to movement artifacts must be developed. In Aim 1, We will de-
velop and optimize an OPM-MEG recording system for use in children. We have already developed a weara-
ble OPM-MEG helmet for use in adults. We will extend this method by designing age-matched helmets that
can be comfortably worn by children with optimized fit. Moreover, in children, head movements create addi-
tional artifacts due to the movement of sensors within the background field gradients. We will develop addi-
tional nulling coils to fully cancel the background gradient fields and software to adaptively cancel drifting
fields thereby suppressing these artifacts. In Aim 2, we will evaluate the system first on healthy children using
somatosensory evoked responses. We will compare the estimated dipole locations during natural head
movements in OPM-MEG and SQUID-MEG. Then, we will apply it on pediatric patients for the detection of
IEDs and compare the confirmed IED locations from intracranial EEG to the estimated source locations from
OPM-MEG and SQUID-MEG.

Public health relevance
Project Narrative Childhood epilepsy accounts for 15% of total epilepsy cases in the US and more than 10.5 million cases worldwide. Magnetoencephalography (MEG) is an established tool for pre-surgical evaluation of adult patients with drug-resistant epilepsy, but it is unavailable to the pediatric population due to fixed adult-sized helmets. The goal of this proposal is to develop a new on-scalp pediatric MEG system that works for children of ages 4- 17 years and establish its utility in localizing interictal epileptiform discharges (IEDs).